Kidney Therapeutics: Translating Discoveries into Prevention, Treatment and Cures for Kidney Diseases

PROJECT SUMMARY TO OVERALL COMPONENT
Despite recent discoveries that explain the molecular pathogenesis of a number of kidney diseases, new
therapies have been slow to emerge. With a staggering 30 million Americans suffering from kidney diseases,
there is an urgent unmet need to facilitate development of new treatments. The overall theme of the proposed
Northwestern George M. O’Brien Kidney Core Center named NU-GoKIDNEY, will focus on Kidney
Therapeutics – to translate discoveries into prevention, treatment and cures. To realize this objective, requires
extensive and productive collaborations between multiple scientific and clinical disciplines that do not
traditionally interact. Our Center will unite investigators across three Cores: the Pre-Clinical Models Core
(Core A), the Therapeutics Development Core (Core B) and the Clinical and Translational Core (Core
C). The Center will nucleate unique, unparalleled talent available at Northwestern University to accomplish this
goal, including: 1) an exceptional group of interdisciplinary kidney researchers; 2) large collection of relevant
animal models and cell lines; 3) a world-leading nanomedicine institute; 4) an innovative and world-class
chemistry department devoted to drug discovery; 5) world-leading bio-electronics expertise; 6) a renowned
team of experts in pharmacogenomics and pharmacology; 7) a high level Good Manufacturing Practices
(GMP) production facility developed by one of the core directors; 8) an electronic data warehouse comprising
6.7M individual patients linked to genomic data; 9) large biorepository of renal specimens; 10) expertise and
infrastructure to conduct first-in-human studies; 11) track record of community engagement in the conduct of
research and 12) an Innovation and New Ventures office (INVO). In addition to the establishment of the three
biomedical cores, the NU-GoKIDNEY Center will support innovative Enrichment programs and Pilot and
Feasibility studies designed to enhance cross-disciplinary collaborations, attract new investigators into the
kidney diseases field and train the next generation of kidney innovators. An online portal nephro-HUB will
provide access to these unique NU resources - for the first time - to the outside world and a Kidney Cure
Accelerator will be launched to promote therapeutic innovation and catalyse translation within Northwestern
and across the Chicagoland, national and international kidney communities.

Public health relevance
OVERALL PROJECT NARRATIVE Chronic kidney diseases affect more than 30 million Americans placing them at major risk for cardiovascular events, other comorbidities and death. The cost of care for the ~ 650,000 Americans with end-stage renal disease exceeds 28% of the total medi-care budget. These staggering statistics underscore the urgent need to identify new treatments. The major objective of the George M. O'Brien Kidney Research Core Center at Northwestern University (NU-GoKIDNEY) is to promote and support research into the Discovery of Novel Therapeutics that will transform the prevention and treatment of kidney diseases and eventually lead to cures.